Motor learning of protective responses to balance perturbations in persons with Parkinson's Disease

Project Summary
Two-thirds of persons with Parkinson’s disease (PwPD) fall yearly, resulting in non-fatal and fatal injuries. Many
of these patients are recurrent fallers, due primarily to parkinsonian symptoms that interfere with postural control
and limit postural responses to both self-initiated and external perturbations. These symptoms cause excessive
co-contraction of agonists and antagonist muscle groups, hypometria, delayed stepping, and postural set
inflexibility (i.e., an inability to quickly change responses to different types, conditions, and intensities of postural
disturbances). Even with pharmacological and rehabilitation interventions, postural and balance deficits persist,
and the risk of falls remains intractable. Among older adults, balance perturbation training is emerging as an
effective method to reduce fall related injuries. In PwPD, however, one of the challenges to balance training is
that postural inflexibility may negatively impact motor skill acquisition, retention, and generalization. As a result,
motor learning strategies that are effective in individuals without PD may not be effective in PwPD. The overall
objective of this PhD dissertation proposal is to determine the effect of practice schedule on the acquisition,
retention, and generalization of protective balance responses in PwPD. The central hypothesis is that PwPD will
acquire and retain protective balance responses to treadmill perturbations through blocked, but not random,
initial practice schedules, and will require a follow-up set of random practice to generalize improvements to
overground perturbations. In specific aim 1, I will compare improvements in protective stepping stability after a
single session of blocked versus random practice of 10 slips and 10 trips in PwPD and age-matched healthy
controls. In specific aim 2, I will compare generalization of protective stepping stability to unpracticed overground
slip perturbations after blocked, followed by random practice sessions (blocked-random) to random, followed by
blocked (random-blocked) practice sessions of treadmill-induced perturbations (10 slips and 10 trips) in PwPD
and controls. Together, these findings will provide a basis for developing balance rehabilitation protocols based
on motor learning principles to mitigate falls in PwPD compared to age-matched controls.

Public health relevance
Project Narrative This aim of this dissertation proposal is to investigate the effect of motor learning practice schedule on the acquisition, retention, and generalization of protective balance responses in individuals with Parkinson’s Disease. Positive findings will provide support for the development of balance rehabilitation protocols based on motor learning principles to mitigate falls in individuals with PD compared to age-matched controls. Since two- thirds of individuals with PD fall yearly, results of this research will have a broad impact on public health.